Investigating MHC-I downregulation by HIV-1 Nef using cryo-electron tomography with laser-based phase contrast

Project Summary/Abstract
Nef is a viral accessory protein which plays a critical role in the pathogenesis of HIV. Among other functions,
it undermines the host immune response by downregulating MHC-I expression at the cell surface. By binding
the clathrin adaptor AP-1 and its cofactor, the GTPase Arf1, Nef drives the formation of AP-1:MHC-I complexes.
This sequesters MHC-I in clathrin-coated vesicles which are eventually trafficked to the lysosome. However, this
mechanism is only partially understood. Cryo-electron tomography (cryo-ET) is a powerful method which can
visualize the interactions between AP-1 and Nef on physiological membranes. Recent work in the Hurley lab
used cryo-ET to visualize the interactions between Nef and AP-1 on membranes in vitro, finding that the complex
forms a lattice. The reconstruction indicated that Nef stabilizes, but is not essential for, lattice formation,
suggesting that an AP-1:Arf1 lattice forms as part of normal clathrin-mediated trafficking and that this lattice is
hijacked by Nef to downregulate MHC-I. However, the resolution remains limited by the poor signal-to-noise ratio
(SNR) of cryo-ET. In the proposed work, the SNR of cryo-ET will be increased in order to test this hypothesis
with unprecedented resolution. To increase SNR, the laser phase plate (LPP), a technology developed in the
Müller lab, will be integrated into a latest-generation aberration-corrected cryo-electron microscope. In Aim 1,
the LPP will be benchmarked against standard, defocus-based cryo-electron microscopy by performing single-
particle reconstructions of the purified model protein, apoferritin. This will demonstrate the first atomic resolution
imaging with the LPP and thus introduce a powerful new imaging modality to the structural biology toolbox. In
Aim 2, the work of the Hurley lab will be built upon by using the new imaging method of laser-based phase
contrast cryo-ET to solve the structures of membrane-bound AP-1:Arf1 complexes in both the presence and
absence of Nef. Comparison of the observed structures will elucidate the mechanism by which AP-1 assemblies
are co-opted by Nef to downregulate MHC-I. In addition, these reconstructions will provide the first structural
data of AP-1:Arf1 complexes on membranes and may reveal the structural basis for AP-1 and Arf1 residues
associated with other human disease. More broadly, the proposed research will introduce a new technology,
laser-based phase contrast cryo-ET, to the structural biology community. This work will also provide deep
structural insights into trafficking in healthy and HIV-infected cells, which may be instrumental in uncovering the
mechanisms of HIV pathogenesis and inform therapeutic approaches. This research will leverage the expertise
of the Hurley lab in membrane reconstitution and HIV biology as well as the unique electron-optical
instrumentation developed by the Müller lab. The training plan proposed in this application and the results of the
project will serve as the foundation for a transition into an independent research career.

Public health relevance
Project Narrative HIV-1 Nef undermines the human immune system, in part by diverting key antiviral host receptors away from target membranes through disruption of membrane protein trafficking machinery. The proposed research develops and applies a new imaging method, laser-based phase contrast cryo-electron tomography, to reveal the structural mechanisms by which Nef hijacks clathrin adaptor protein complex 1 on membranes to deregulate trafficking of MHC-I. Results will yield new insights into Nef function that will inform strategies for the development of HIV therapeutics.